Program Leaders

KCI requests funds for five Program Leaders and seven Program Co-Leaders. These individuals and their respective roles and responsibilities are described in detail within each Program narrative: 1) Breast Cancer Biology Program, Section 8.0.1; 2) Developmental Therapeutics Program, Section 8.0.2; 3) Molecular Biology and Genetics Program, Section 8.0.3; 4) Population Studies and Disparities Research, Section 8.0.4; and 5) Proteases and Cancer Program, Section 8.0.5.

Public health relevance
Five Program Leaders and seven Program Co-Leaders provide leadership to each of the five scientific Programs by developing and implementing strategic planning for the Programs, facilitating intra- and interprogrammatic interactions, leading Program meetings, mentoring junior faculty, and advocating for shared resource facilities.